PCR-free UPLC-MS/MS based quantitative assay of microRNAs

Project Summary
Aberrant expression of microRNAs has been found associated with pathological conditions. Over the past years
many putative miRNA-based disease biomarkers have been reported, but none of them has been fully validated
(e.g., for FDA approval). This is largely because of the lack of an analytical methodology that offers accurate,
repeatable, and cost-effective quantification of microRNAs present at very low levels in biological specimen. The
current golden standard for microRNA assay (i.e., quantitative reverse transcription polymerase chain reaction,
RT-qPCR) offers “a relative quantification” and is very high in assay cost (>$15 of consumables /per assay).
After all, all PCR-based quantitative assays deploy a calibration curve established between fluorescence signal
and the logarithm of microRNA concentration (instead of microRNA concentration), which by nature produces
less accurate quantitation results and exponentially amplifies the uncertainties contained in fluorescence signal
measurements. The goal of the research is to eliminate current limitations in quantitative assay of microRNAs,
thus fostering the biomedical research and full validation of these emerging disease biomarkers. We propose
herein a novel analytical strategy for “absolute quantification” of target microRNAs based on robust and popular
ultra-performance liquid chromatography-tandem mass spectrometry (UPLC-MS/MS) in combination with affinity
magnetic solid phase extraction and isothermal signal amplification. The strategy involves the following PCR-
free workflow: 1) target microRNA is extracted /enriched from a biological sample by using an ssDNA probe-
magnetic bead conjugate; 2) solid surface polyadenylation of target microRNA captured by poly(A) polymerase
with 13C-labeled adenine; and 3) UPLC-MS/MS determination of 13C-labeled adenine after acid hydrolysis of the
extended target microRNA. The quantitative assay is expected to have the following assay characteristics: high
sensitivity (LOQs < 1pM, a physiologically relevant level), high accuracy (recovery ≥ 95%), good repeatability
(RSD ≤ 5%), the capability of single base mismatch discrimination, no need for a total RNA isolation in the assay,
and cost-effectiveness (a total cost of consumables < $1.5 per assay. Implementation of this analytical method
will have a profound impact on microRNA biomedical research.
The project proposed fits the research concentration at Jackson State University and will be able to draw
students from the Chemistry and Biology programs. The participating students will acquire lab skills including
cell culture, biological sample preparation, instrumental analysis, and scientific data process /presentation
through research activities. In general, the project will help to develop and to sustain research excellence at JSU
(an HBCU), and thus contribute to the diversity of our future research workforce.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Liu, Yiming Over the past years numerous microRNAs have been reported as biomarkers associated with various medical conditions. The current golden standard for microRNA assay, i.e., quantitative reverse transcription polymerase chain reaction (RT-qPCR), has disadvantages such as inadequate assay accuracy and high-assay costs. We propose herein to develop a novel analytical strategy based on the reliable UPLC- MS/MS technique to achieve highly sensitive absolute quantification of targeted microRNAs in biological samples, thus fostering the biomedical research and full validation of these emerging disease biomarkers. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page